Translational Research Training Program in Environmental Health Sciences

This application is the second competing continuation of a T32 Institutional Training Grant in Environmental
Health Sciences (EHS) entitled: “Translational Research Training Program in EHS” (T32-ES019851) at the
University of Pennsylvania (Penn). This training grant is the only dedicated mechanism to support formalized
EHS research training at the pre- and post-doctoral level at Penn and meets a significant need based on trainee
interest in the environment and its health impact and biomedical work force need. The mission of the T32
Training Program is to train the next generation of environmental health scientists to identify the
mechanisms by which environmental exposures cause disease and to translate these findings into
effective prevention and treatment and improvements in public health. The research training reflects the
translational research themes of Penn’s P30 Environmental Health Sciences Core Center, the Center of
Excellence in Environmental Toxicology (CEET). These themes include: Air Pollution and Lung Health,
Environmental Exposures and Cancer, Windows of Susceptibility and Environmental Neuroscience. These
themes are underpinned by exposure assessment, adverse outcomes, and translation to human subjects,
communities and policy. Training is provided through course work from the Certificate Program in Environmental
Health Sciences which includes a mandatory Community Environmental Health Rotation, by conducting a full-
time translational research project co-mentored where possible by a basic-scientist and clinician-scientist to
generate new knowledge in EHS. The 48 distinguished Training Grant (TG) faculty come from Penn and
Children’s Hospital of Philadelphia, 22 are clinician-scientists and 21 are women. The TG supports common
experiences including a research club, a dedicated seminar series, an annual symposium dedicated to a
translational research theme, and optional externships at US EPA, the Silent Spring Institute, the Research
Institute for Fragrance Materials and a Science Policy Institute so that trainees are exposed to alternative career
options. The T32 award currently supports three predoctoral fellows to conduct dissertation research on an EHS
topic and four postdoctoral fellows to perform mentored EHS research. Predoctoral trainees are supported for a
total of three years (2nd year completion of the Certificate Program in EHS and two years dissertation research)
and postdoctoral trainees are supported for two to three years. Trainees are prepared for a suite of careers in
the employment sector e.g. academia (in EHS, Pharmacology and Toxicology), government agencies (e.g. US-
EPA, CDC, FDA, NTP, NIEHS); and industry (drug, food, cosmetic and nanotechnology). In the last two cycles
the Training Grant has supported 29 trainees, who have published 108 papers and alumni have continued with
scientific careers in academia and industry. Since the last competitive renewal 38% of the trainees were
underrepresented in science and 56% were women.

Public health relevance
Narrative: This T32 Training Program is dedicated to the training of the next generation of environmental health scientists by emphasizing training in translational research that transcends basic and population based research, patient oriented research, community engagement and public health policy.